Proteomic determinants of direct measures of insulin sensitivity

The consequences of insulin resistance (IR) include not only type 2 diabetes mellitus but also a cluster of
metabolic abnormalities that double the risk of developing life-threatening complications of atherosclerosis
including myocardial infarction, ischemic strokes, and peripheral arterial disease. The prevalence IR is
increasing at an alarming rate as western populations become heavier and more sedentary. When one further
considers the ongoing epidemiological transitions in developing countries in addition to the obesity epidemic in
developed countries, the worldwide public health impact of IR is undoubtedly profound. Few pharmacological
options exist that improve one’s insulin sensitivity and decrease the risk of complications from IR and recent
genomic studies of surrogate measures of IR have yielded a disappointing number of new leads. Furthermore,
a critical need exists for the development of more accurate blood-based diagnostic tests for IR. The long-term
objective of the proposed research is to discover and validate novel protein markers of IR circulating in the
blood of individuals who have undergone either one of the two ‘gold standard’ direct measures of insulin
sensitivity: an insulin suppression test (IST) or a euglycemic clamp (EC). This information will be used to
identify novel molecular pathways of IR that can be targeted pharmacologically and to develop statistical
models that correlate highly with the degree of IR as estimated by direct measures of insulin sensitivity. In aim
1 of this proposal, the blood of 2100 white/European subjects who have undergone an IST at Stanford or an
EC in the Relationship between Insulin Sensitivity and Cardiovascular Disease (RISC) and the Uppsala
Longitudinal Study of Adult Men (ULSAM) studies will be measured for the presence of 981 proteins using an
emerging platform that leverages novel technology referred to as the proximity extension assay. This
technology allows for the accurate and reliable quantification of proteins in plasma down to the femtomolar or
attomolar level. We will further validate the top signals identified in these subjects in an additional ~300 non-
European subjects and a subset of 300 subjects from Stanford who underwent a second IST after weight loss
or use of a thiazolidinedione. In aim 2, we will examine validated signals from Aim 1 for causality using the
principal of Mendelian randomization, and we will quantify improvements afforded by validated markers over
conventional measures in identifying subjects at risk of complications from IR. In aim 3, validated associations
between proteins that appear causal in nature will be further examined through knockdown of the genes
producing these proteins in human cell lines relevant to IR. These cell lines will include adipocytes,
hepatocytes, and skeletal myocytes. This study is the largest study of the plasma proteome in relation to direct
measures of insulin sensitivity ever proposed. Findings are expected to yield important mechanistic insights
into the molecular basis of IR and provide the foundation for the development of a blood-based diagnostic test
that can very reliably detect subjects at low or high risk of complications from IR.

Public health relevance
Insulin resistance is a physiological state that predisposes to the development of Type 2 diabetes as well as plaque buildup in the arteries of the heart, neck, and brain which can result in heart attacks or strokes. In this proposal, we will comprehensively examine the levels of many proteins in the blood of individuals who underwent laborious ‘gold standard’ testing for the presence of insulin resistance. We will use this information to better understand the causes of insulin resistance and to improve our ability to identify individuals at risk of complications of insulin resistance.